Impact of cannabis legalization and commercialization on substance use and mental health outcomes in psychosis

Project Summary
Legalization of cannabis and subsequent expansion of commercial cannabis markets are spreading
rapidly across the United States. While many can use cannabis without significant harm, individuals with
serious mental illnesses such as schizophrenia and other psychotic disorders are disproportionately likely to
experience harms from cannabis use, and cannabis commercialization could worsen outcomes for this
vulnerable population. As an early career psychiatrist and health services researcher with specialty interests in
addictions and psychosis, I am proposing to use quasi-experimental difference in difference methods to study
the effects of commercialization on cannabis use and mental health outcomes among individuals with
psychosis. I am first proposing to analyze the Population Assessment of Tobacco and Health (PATH) study to
probe the effects of the opening of commercial cannabis markets on cannabis and other substance use among
individuals with psychosis (Aim 1). Next, I will utilize data from an NIH funded consortium of first episode
psychosis clinics, the Early Psychosis Intervention Network (Epinet), to assess the effect of commercialization
on substance use, psychosis relapse (emergency department visits and psychiatric hospitalizations), and
secondary outcomes including criminal legal involvement among youth and young adults with early psychosis
(Aim 2). Triple difference methodologies will be utilized in each analysis to measure whether commercialization
is linked to health disparities, both between individuals with psychosis and the general population (Aim 1) and
between majority and minoritized racial and ethnic individuals with psychosis (Aim 2).
In the proposed training plan, I will develop expertise in: 1) substance use disorder research, policy, and
implementation, 2) statistical methods for causal inference including difference in difference designs, and 3)
rigorous analysis of health disparities to inform clinical and policy efforts to improve outcomes for vulnerable
populations. The research will take place at the Cambridge Health Alliance, a public sector teaching hospital of
Harvard Medical School, within the Health Equity Research Lab which has deep experience in health policy
and health disparity research in large datasets. In line with NIDA’s strategic plan, this proposal will study “the
effects of local, state, and national drug policies on public health” (Goal 1.3 2022-26) and will lay the foundation
for my development into a leading health services and policy researcher straddling clinical and public health
realms to develop substance use policies that maximize benefits and minimize harms for vulnerable
populations. Subsequent R01 proposals will study the effects of commercialization on incidence of first episode
psychosis in national claims data as well as the effects of public health policies (ex. marketing and advertising
limits, health warnings, and potency limits) on individuals with serious mental illness.

Public health relevance
Project Narrative Cannabis legalization and expansion of availability in commercial retail settings has resulted in increased use among the general population, but its effect on vulnerable groups such as individuals with schizophrenia and other psychotic disorders is not known. This proposal will investigate two large datasets to explore whether the expansion of commercial cannabis markets is associated with increased substance use as well as poorer mental health among individuals with psychosis, with a special focus on individuals from minoritized racial and ethnic groups. Understanding this relationship will allow policy makers and regulators to implement drug policies that maximize benefits and minimize harms to vulnerable populations such as individuals with severe mental illness.